Visual Cortex as a Window to Microstructural and Functional Development of the Human Brain

Project Summary
Babies are a highly vulnerable population for which the ability to diagnose atypical vs. typical visual cortex
development and intervene early could not be of greater importance. However, how infant visual cortex develops
microstructurally and functionally is largely unknown outside primary visual cortex (V1). The goal of this research
is to fill glaring gaps in knowledge by: (i) Using innovative quantitative (qMRI), diffusion (dMRI), and functional
(fMRI) magnetic resonance imaging, to longitudinally measure and examine the relationship between
microstructural and functional development of the human visual system during the first two years of life (Aim 1).
(ii) Using advanced histological and quantitative methods in pediatric samples of visual cortex, determine the
biological underpinnings of microstructural development (Aim 2). Specifically, Aim 1a will use qMRI and dMRI
to longitudinally measure the microstructural development of infant visual cortex from 0-24 months. We will: (i)
test if development varies across visual areas, and (ii) examine if microstructural development is associated with
tissue pruning or proliferation. Aim 1b will use dMRI and qMRI to longitudinally measure the microstructural
development of the white matter tracts of the infant visual system from 0-24 months and examine the relation
between white and gray matter development. Aim 1c will use fMRI to: (i) examine the development of cortical
responses to visual contrast, which rely on processing in V1, and responses to visual categories, which rely on
processing in high-level visual regions in ventral temporal cortex (VTC), and (ii) determine if and how functional
development is related to microstructural development in the same infants. Aim 2 will augment and validate in
vivo metrics using ex vivo histology in tissue samples of 0-24 months-olds. Aim 2a will use quantitative histology
to (i) measure the development of cortical myelination in V1 and VTC, and (ii) relate histological data to in vivo
metrics to determine which neuroimaging metrics are coupled with myelination. Aim 2b will: (i) quantify the
densities of multiple cell types (all cells, neurons, astrocytes, and oligodendrocytes) in V1 and VTC, and (ii) test
if development varies across cortical expanses and if it is tied to myelination. Aim 2c will use transcriptomic
analyses to determine gene expression pathways and elucidate molecular signaling pathways associated with
microstructural development in V1 and VTC. The proposed research is highly innovative and groundbreaking as
it will provide the first combined in vivo and ex vivo measurements of the microstructural and functional
development of human visual cortex in infancy. This research is important as it will not only fill significant gaps
in knowledge but also will develop novel, cutting-edge, and open-source methodologies for quantitative
measurements of cortical microstructure that are linked to biological mechanisms. Thus, the proposed research
has broad societal and clinical impact as it will lead to development of non-invasive biomarkers to diagnosis
atypical visual cortex development in infants, leading to early inventions and better life-long outcomes.

Public health relevance
Project Narrative Our proposed research is in-line with the mission of the NEI to advance knowledge of the neural mechanisms of visual function. We expect our proposed research to significantly advance the understanding of how the microstructure and function of the human visual system develops during the first two years of life. The outcome of our research will improve the well-being of individuals in society as it will provide foundational knowledge leading to the development of noninvasive biomarkers to diagnosis atypical development of visual cortex in infants, leading the way to early inventions and better life-long outcomes.